Y Chromosome Evolution

PROJECT SUMMARY
The male-specific Y chromosome is critical for sex determination and fertility. Yet, because of its highly
repetitive structure and haploidy, its sequence has only been deciphered for a handful of mammalian species,
including just three apes ‒ human, chimpanzee, and gorilla. The lack of Y chromosome sequences has made it
difficult to obtain a complete picture of mammalian genome evolution, and has hampered studies of sex-
specific dynamics in natural populations. In this project, we have chosen to study evolution of ape Y
chromosomes because they differ enormously among species at the cytogenetic level, and because mating and
dispersal patterns, which influence selection and genetic drift acting on the Y, vary dramatically among apes.
Our goal is to decipher the evolutionary processes shaping ape Y chromosome evolution by examining Y
interspecific divergence and intraspecific diversity. In Aim 1 we will study evolution of ape Y chromosome
architecture. Applying our novel method based on the latest experimental and computational techniques, we
assembled the Y chromosomes of gorilla, bonobo, and Bornean orangutan. Using these and publicly available
ape Y assemblies in a phylogenetic framework, we will study several features of Y chromosome architecture:
sequence divergence, gene content, and transposable element accumulation. Instances of lineage-specific
accelerated or decelerated evolution of Y chromosome evolution will be identified and their causes will be
explored in subsequent aims. In Aim 2 we will investigate evolutionary forces affecting global Y chromosome
architecture by studying Y chromosome diversity. We will test whether the observed diversity patterns, as
inferred from publicly available and in-house generated re-sequencing data, are consistent with random
genetic drift or with positive or negative selection. In Aims 3 and 4, the selection targets will be identified. In
Aim 3, we will decipher the individual gene sequences from short- and long-read transcriptome assemblies,
construct gene phylogenies, and test for lineage-specific selection acting on individual genes and on individual
gene copies for multi-copy gene families. Aim 4 will evaluate potential selection acting on the expression
levels and copy number of multi-copy ampliconic gene families on the Y chromosome. These genes are
expressed during spermatogenesis and their deletions have been implicated in human male infertility. Overall,
our project will have important implications for uncovering the intricacies of ape genome evolution. The ape Y
chromosome assemblies, alignments, and transcript catalogues will serve as an invaluable resource for
addressing a myriad of long-standing biological questions and for designing genetic markers to trace the
dispersal of male apes in the wild. This is critical, as all studied ape species are endangered. The techniques
developed for this project will be shared with other researchers, enabling them to study Y chromosomes of
other species. Our thorough investigation of evolution of ampliconic gene sequence, expression levels, and
copy number will significantly contribute to our understanding of the causes of male infertility.

Public health relevance
PROJECT NARRATIVE The male-specific Y chromosome harbors genes that are expressed in spermatogenesis and are known to be deleted in infertile males. We propose to study the Y chromosome and thus our research will have major consequences for our understanding of the causes of human male infertility.